Genetic Architecture of Avoidant/Restrictive Food Intake Disorder

Project Summary
We propose to rapidly accelerate our understanding of the biology of eating disorders by conducting the first
genomic study of avoidant/restrictive food intake disorder (ARFID): ARFID-GEN. ARFID, first included in the
DSM-5 Feeding and Eating Disorders chapter in 2013, is characterized by food avoidance or restriction due to
three non-mutually exclusive presentations (1) phobic avoidance, (2) sensory sensitivity, or (3) disinterest/low
appetite. Little is known about risk mechanisms and pathophysiology of ARFID, and no genetic studies have
been conducted to date. Ongoing is the Eating Disorders Genetic Initiative (EDGI; R01MH120170), aimed to
further the genomic discovery of the eating disorders: anorexia nervosa, bulimia nervosa, and binge-eating
disorder. Absent from EDGI is the serious, taxing, and potentially life-threatening ARFID. We propose an
efficient genomic analysis of ARFID, by leveraging EDGI operations and resources to conduct the first
genome-wide association study (GWAS) of ARFID. Moreover, by combining ARFID with EDGI, we will achieve
a complete explication of the DSM-5 feeding and eating disorders chapter. Conceptually, our proposal will test
whether ARFID shares a core set of genetic factors with other eating disorders yet is differentiated by a set of
disorder-specific genetic factors.
Using an efficient and economical approach, ARFID-GEN will: (Aim 1) collect 5,000 ARFID cases and 1,000
new child controls with phenotype and genotype information; (Aim 2) conduct the first GWAS of ARFID plus a
standard set of post-GWAS analyses in order to reveal the genetic architecture of ARFID; (Aim 3) apply
advanced analytic strategies to explicate the common and divergent genomic architecture of ARFID and the
other eating disorders; and (Aim 4) explore the genomic relation among ARFID and multiple psychiatric,
metabolic, and anthropometric traits. Launching ARFID-GEN now is the next logical step in eating disorder
genomics.
Our team has been at the forefront of eating disorder genetics research. Deliverables of the proposed specific
aims include: (a) Analysis-ready deep phenotypic and genotypic datasets from the largest ARFID collection in
the word; (b) ARFID GWAS; (c) defining the genetic relation of ARFID with other eating disorders; (d) genetic
assessment of ARFID’s relation to other phenotypes, informing and refining etiology. The proposed aims will
not only reveal the underlying genomic architecture of ARFID, but combined with other ongoing studies and
existing data, fully explicate the feeding and eating disorders chapter of the DSM-5, affording the development
of a genetically-informed nosology. Given pharmacological treatments for all eating disorders are lacking, we
will have created a complete map of the genomics of ARFID, and the eating disorders, that will open avenues
for pharmacogenomics and the repurposing and development of medications that target disease biology.

Public health relevance
Project Narrative Avoidant/Restrictive Food Intake Disorder (ARFID) despite being serious, taxing, and potentially life- threatening is absent from efforts to define the genomics of the feeding and eating disorders. We propose ARFID-GEN to explicate the genetic architecture of ARFID and, combined with other ongoing eating disorder genomic studies, to map the genetic architecture of the feeding and eating disorders relative to each other. Unraveling the genetic architecture of ARFID will contribute to the understanding of this relatively new disorder and may open avenues for pharmacogenomics and the repurposing and development of medications that target underlying disease biology.